Enhancing SARS-Co-V-2 Rapid Testing Acceptance in Latinx Communities

This project employs a data-informed approach for implementing preventive interventions designed to
advance health equity and ameliorate health disparities among vulnerable populations. Building on the
successful Phase I and II projects, we will further tailor the Promotores de Salud COVID-19 evidence-based
health promotion intervention to experimentally evaluate a brief behavioral self-affirming implementation
intention (SAII) intervention; an approach that is evidence-based for increasing acceptance of health
messaging, increasing intentions to change, increasing health promoting behaviors, and decreasing
psychological distress. We hypothesize (a) the SAII will increase SARS-CoV-2 rapid testing, testing and
vaccine acceptance, and health outcomes through enhancing health promotion messaging, reducing stigma,
and affirming self-perceptions; and (b) the SAII will serve as a buffer that moderates (lowers) negative effects
of COVID-19-related stressors and discrimination on testing and health outcomes. The key targets of the
intervention will be structural social determinants of health (i.e., discrimination and mistrust) as barriers to
testing acceptance. Project aims are: (1) To pilot test rapid SARS-CoV-2 test distribution and an English and
Spanish version of the SAII intervention. The culturally tailored SAII intervention will be offered in Spanish and
English and can be administered orally and does not require English language proficiency or literacy; and (2)
conduct a clustered randomized trial (CRT) testing a health equity effectiveness hypothesis. We will use a 2-
group × 2-time (pre-post) design to randomly assign 400 participants sampled from Mexican Consulate event
attendees to either an SAII + Promotores de Salud condition or to a control condition (the Promotores de Salud
intervention only) and test (a) hypothesized main effects of the intervention on testing and vaccine acceptance
and health outcomes, and (b) hypothesized buffering effects of COVID-19 stressors and discrimination on
testing and health outcomes. Linear and generalizable multilevel structural equation modeling will be specified
for evaluation. The study design is powered to detect moderate main effects (ES = .30) and moderating effects
of the SAII intervention.

Public health relevance
This project employs a data-informed approach for implementing preventive interventions designed to advance health equity and ameliorate health disparities among Latinx communities. We will culturally adapt the brief self-affirmation implementation intentions (SAII) intervention. Effectiveness will be tested using a 2-group × 2- time (pre-post) design to randomly assign 400 participants sampled from Mexican Consulate event attendees to either an SAII + Promotores de Salud condition or to a control condition (the Promotores de Salud intervention only).